Mechanisms of Dual Inhibition of TGFbeta/PD-L1 in HNSCC

SUMMARY
Squamous cell carcinoma (SCC) accounts for over 90% of head and neck (HN) cancer. HNSCCs in heavy
smokers respond poorly to therapies and have the highest rate of relapse/recurrence among all HNSCC
patients. Inhibitors of programmed death-1 (PD-1) are FDA approved to treat relapsed/recurrent HNSCCs, but
are only effective in ~25% of HNSCCs, indicating additional immune suppressive/evasion mechanisms. We
reported that transforming growth factor-β1 (TGFβ1), an immune suppressor, is elevated in >60% of tobacco-
associated HNSCCs. Unique to HNSCC, TGFβ1 causes excessive inflammation with the majority of tumor
infiltrating leukocytes being myeloid cells. Developing new therapeutic interventions that effectively target these
tumor microenvironment (TME) characteristics is hindered by a dearth of HNSCC models with metastatic
potential in an immune competent background. This application employs new therapeutic agents to target both
PD-L1 and TGFβ in HNSCC and metastasis, and analyze the underlying mechanisms. We have created a
mouse model in which Smad4, a tumor suppressor frequently lost in tobacco-associated HNSCCs, is deleted
(Smad4-/-) in head and neck epithelia. Smad4 loss causes SCC and metastasis, and compensatory TGFβ1
overproduction. Preliminary data revealed that Smad4-/- SCCs also overexpress PD-L1 and short-term TGFβ
inhibition sensitized SCCs to anti-PD-L1. Further, in mice with SCC eradicated, re-transplanting the same SCC
cell line failed to initiate new tumors, suggesting a memory T cell-dependent anti-tumor response. TGFβ
inhibition also reduced SCC lung metastases in immune compromised mice. Taken together, we hypothesize
that attenuating a TGFβ-induced immune suppressive and inflammatory TME in Smad4 mutant
HNSCCs makes immunotherapy more effective, thus dual TGFβ/PD-L1 inhibition eradicates these
HNSCCs via T-cell-dependent and -independent mechanisms. Aim 1 will perform experimental
therapeutics using novel TGFβ/PD-L1 inhibitor drugs on genetic mouse models and transplanted human
HNSCCs to determine if Smad4 loss and TGFβ1 overexpression predict therapeutic response to TGFβ/PD-L1
dual inhibition in HNSCCs in immune competent and compromised conditions. Aim 2 will assess T cell-
dependent mechanisms of TGFβ inhibition on sensitizing or synergizing with anti-PD-L1-mediated SCC
eradication, utilizing tumors generated in Aim 1 and patient HNSCC specimens to examine if Smad4 loss and
TGFβ/PD-L1 levels correlate with immune suppressive T cell profiles. Aim 3 will use tumors generated in Aim
1 to assess if myeloid cell-dependent targeting effects of TGFβ/PD-L1 inhibition contribute to therapeutic
efficacy in HNSCC and metastasis, and patient HNSCC specimens to examine if Smad4 loss and TGFβ/PD-L1
levels correlate with increased myeloid cells and associated molecular markers. These studies will lead to a
novel therapeutic strategy for HNSCC patients with high rates of recurrence and metastasis. Additionally, the
mechanistic studies will offer novel insights into future biomarker-driven selection for future clinical trials of
TGFβ/PD-L1 dual inhibition in HNSCC patients.

Public health relevance
NARRATIVE We will use genetically engineered mouse models and human cancer transplantations to test novel therapeutic strategies for head and neck cancer in a patient population resistant to currently available therapies. We will also use human cancer specimens to validate cellular and molecular targets of novel therapies. The proposed studies aim to identify novel mechanisms of the proposed therapeutic intervention, and provide important insight into the design of future clinical trials in patients who have head and neck cancer with very poor outcomes.